Vascular Endothelial Function: A Potential Therapeutic Target in Alzheimer's Disease

The medical, social, and economic burdens that Alzheimer's disease (AD) and the prodromal stage of this
pathology, mild cognitive impairment (MCI), place on Veterans has stimulated efforts to identify therapeutic
targets to modify their progression. Recent evidence suggests that, in addition to vascular abnormalities in AD,
a deficiency in endothelium-derived nitric oxide (NO) may contribute to the production and accumulation of AD-
related neurotoxins such as amyloid beta (Aβ). As challenges, which we are uniquely poised to overcome,
have deterred the in vivo assessment of cerebral endothelial function and NO bioavailability, it is unclear if
these factors are, indeed, attenuated in AD. Therefore, the first aim of this study is to determine if endothelial
function is related to AD severity by measuring the change in cerebral blood flow elicited by the intravenous
infusion of the NO synthase (NOS) inhibitor NG-monomethyl-L-arginine (L-NMMA) to directly assess cerebral
NO bioavailability in patients with AD, MCI, and cognitively-normal age and sex matched controls. We also
propose to determine if simpler, non-invasive assessments of peripheral endothelial function are good
surrogates for cerebral endothelial function. The second aim of this study will determine the role of endothelial
function and NO bioavailability in AD progression by longitudinally assessing and comparing the change in
endothelial function (cerebral and peripheral) to the change in cognitive function over the course of 18 months
in patients with MCI and age and sex matched controls. Thus, the overall goal of the proposed studies is to
better understand the role of the vascular endothelium in AD severity and progression to determine if cerebral
endothelial function and NO bioavailability are viable therapeutic targets to limit this debilitating disease.

Public health relevance
The growing prevalence of Alzheimer’s disease (AD) and its preliminary stage, mild cognitive impairment (MCI), among U.S. Veterans has stimulated efforts to identify therapeutic targets to modify the progression of these debilitating, neurodegenerative diseases. Recent evidence suggests that dysfunction of the vascular endothelium and decreased abundance of its product, nitric oxide (NO), may contribute to the production and accumulation of neurotoxins thought to cause AD, making endothelial NO bioavailability a potential therapeutic target for the treatment of AD. Therefore, the purpose of this study is to determine if endothelial function and cerebral NO bioavailability are related to the severity and longitudinal progression of AD. Ultimately, these findings will help determine if endothelial function may serve as a prognostic indicator, as well as a potential therapeutic target, in the fight against AD.